Silent Functional MRI Using Looping Star

Project Summary: Silent Functional MRI using Looping Star
Functional brain imaging using MRI (functional MRI or fMRI) has grown rapidly in use over the past 30 years
and is now widely used for basic cognitive neuroscience research and for presurgical planning. It is
increasingly being used for developing biomarkers for neurological and psychiatric disorders and for
population-based studies of, for example, normal and abnormal development and aging. While there have
been numerous advances to fMRI technology that have improved the sensitivity and specificity of the method,
many practical challenges remain, for example, the impact of acoustic noise and head movement.
The presence of acoustic noise is problematic for fMRI studies in a number of ways. Most obviously are the
unpleasant aspects of the loud MRI scanner that can create issues for studies of children and patients with
dementia. Studies requiring precise hearing, such as studies of auditory discrimination and processing of
natural language are greatly influenced by loud scanner noises. In addition, numerous studies have shown
alterations in brain activity in ordinary fMRI studies due to the presence of acoustic noise.
The overarching goal of this project is to develop a silent, whole-brain fMRI acquisition that is capable of
commonly used spatial and temporal resolutions. Our general approach builds off of a class of very quiet MRI
acquisition methods that use very slowly changing gradient waveforms, specifically, a method known as
Looping Star. In our project, we will carefully address the critical needs of SNR, spatial and temporal
resolution, physiological noise and motion, and susceptibility-related distortions through a combination of novel
image acquisition, reconstruction, and processing methods. Our preliminary data suggest that we should be
able to achieve substantial parallel imaging accelerations and improvements in SNR and artifact robustness
over current methods.
The project has four main aims: (1) design and optimize image acquisition for improved SNR, improved
spatiotemporal resolution, and reduced undersampling artifact for LS fMRI acquisitions, (2) develop novel
dynamic image reconstruction methods for improved spatiotemporal resolution in LS fMRI, (3) integrate
corrections into the image reconstruction for physiological noise, head motion, and off-resonance corrections,
and (4), evaluate the looping star fMRI approach in comparison to state-of-the-art simultaneous multislice
acquisition methods in phantoms and in human subjects using both task fMRI and connectivity.
Success in this project will allow quiet, motion and artifact-robust fMRI for studies of children, patients with
dementia, hearing, naturalistic speech, amongst other areas. In addition, we believe it is possible that our
optimized LS fMRI will be robust for most routine fMRI studies in clinical and research environments.

Public health relevance
Public Health Relevance: Functional magnetic resonance imaging (fMRI) is used to measure brain function and has revolutionized our understanding of cognitive processes during the last 30 years and has also been used as a tool for presurgical mapping of language and other sensitive brain regions. More recently, fMRI is being used as a biomarker for the progression of neurologic and psychiatric diseases, for example, in Alzheimer’s disease and major depression. In this project we address the important challenge of reducing acoustic noise during functional imaging studies, which will not only make study more tolerable for many patients but will make fMRI more useful by enabling the use of more relevant and naturalistic stimuli. .